Project 1: Novel gene networks modulating progressive ethanol consumption in DO mice

Project Summary – Pilot Projects
The goals of this Pilot Projects Core of the VCU Alcohol Research Center (ARC) are to: 1) manage the progress
and quality control for our two designated initial pilot projects, 2) solicit and evaluate future pilot grant proposals
to further expand the scientific breadth of VCU-ARC, 3) encourage pilot grant awardees to submit proposals for
independent funding and 4) support training opportunities for students and postdoctoral fellows within
laboratories of funded pilot projects. The first proposed Pilot Project is entitled “Investigating the relationship
between alcohol use, blood pressure phenotypes, and genetics” and will be led by Dr. Elvin Price, a clinical
pharmacologist and translational researcher with extensive training in pharmacogenomics. He will determine if
tag SNPs in VCU-ARC genes of interest impact drinking behaviors and cardiovascular disease phenotypes in a
local cohort recruited from the community through the established Translational Approaches to Personalized
Health (TAPH) study. This project will interact with Project 1, led by Dr. Michael F. Miles, and Project 3, led by
Dr. Amy Lasek. Pilot Project 1 will also interface with the human genetics studies proposed in Projects 4 (Dr.
Dick) and 5 (Drs. Riley, Bacanu, and Nguyen) as new genes influencing the risk for AUD are identified. The
second targeted pilot, entitled “Assess the influence of select dynamic non-SNV genomic variation on AUD risk
and alcohol related outcomes using existing biobank resources including UK Biobank and All of Us” will be
conducted by Dr. B. Todd Webb, an expert in using statistical genetics, bioinformatics, and computational
genomic tools to understand the genetic architecture of complex human diseases such as AUD. He will focus
on the role of telomere length and mitochondrial abundance as indices of dynamic variation in AUD-related
phenotypes. Project 2 will interface with Projects 4 and 5. We will solicit other proposals in year 2 and fund the
two best of them in years 3-4, then solicit proposals again in year 4 to fund one in year 5. The pilot program is
an important component of the VCU-ARC that will enable us to attract new and innovative researchers to interact
with Center investigators and expand high quality alcohol research at VCU.